Core D: Community Outreach and Engagement Core

SUMMARY
The Community Outreach and Engagement (COE) Core D will support participation of SPORE investigators
and community partners, including children and families, advocates, community members, and healthcare
providers, in the full spectrum of community engagement to support achieving SPORE aims.